Determining the Structure and Function of Newly Discovered Immune Systems

Project Summary
Gaining a functional understanding of newly discovered immune systems (e.g. newly discovered CRISPR
systems) will lead to novel molecular tools for use in science and medicine is the overarching hypothesis of my
research program. Over the last 5 years we have generated a large amount of data supporting this hypothesis.
Our efforts uncovered a distinct CRISPR associated (Cas) enzyme called Cas12a2 that can be programmed to
selectively kill cells upon specific recognition of RNA sequence (project 2), creating new possibilities for
targeted cell therapies and gene editing enrichment. With another CRISPR system (Type IV), we discovered
another distinct programmable activity that may be able to be repurposed to silence gene expression while
keeping targeted nucleic acid intact (project 1).
The vision of my research program over the next five years is that we will determine, in deep enough detail,
how the Type IV-A system and SuCas12a2 function to repurpose them as tools while expanding our studies
into related but unstudied immune systems. Our specific goals for project 1 include (i) determining the role of
CasDinG N-terminal domain that is essential for immune system activity, (ii) exploring how Type IV systems
could be used to silence gene expression in mammalian cells, and (iii) determining the structure and function
of other Type IV subsystems (e.g. Type IV-B and IV-C). Our goals for project 2 include (i) defining the
determinants of SuCas12a2 activation by solving structures of Cas12a2 bound to mismatched targets and
distinct PFS sequences and performing kinetic assay with diverse substrates, (ii) determining the distinct
biochemical activities of Cas12a2 orthologs, and (iii) determining structures of Cas12a2 orthologs.
To better understand the biological function of these immune systems, we are using cell-based and
biochemical assays and are determining structures of immune system components at all stages of immunity
using structural methods (x-ray crystallography and cryo-electron microscopy). We aim to determine how these
systems identify their targets, how they distinguish self from non-self, and how distinctions from other immune
systems (protein domains and genes) impact their function. Knowledge of these foundational mechanisms and
their distinctions from existing CRISPR-based tools will be critical for repurposing these immune systems into
novel molecular tools.

Public health relevance
PROJECT NARRATIVE Many immune systems have been repurposed as valuable tools in science and medicine (e.g. antibodies, restriction enzymes, and CRISPR). However, the molecular mechanisms of a large number of immune systems remain unknown, suggesting additional tools are waiting to be discovered. With the hope of identifying novel molecular tools for use in science and medicine, this work aims to understand the structure, function, and molecular mechanisms of unstudied bacterial immune systems.